Trajectories of Physical & Cognitive Functioning in the Neighborhood Environment

Project Summary/Abstract Prevalence of physical and cognitive functioning problems increases dramatically with age. These conditions are associated with mobility challenges, decline in quality of life, increase in falls and bone fractures, loss of independence and increased healthcare costs. Important disparities in these outcomes by socioeconomic status (SES) and race/ethnicity exist. This application seeks to improve knowledge about physical and cognitive functioning and their decline over time in the context of the neighborhood environment, with special emphasis on social and physical aspects of neighborhoods. Additionally, this proposal seeks to further understand how neighborhood environments contribute to race/ethnic and SES disparities in function. This proposed study involves separate secondary analyses of two datasets, including the ongoing MESA (Multi-Ethnic Study of Atherosclerosis) study of 6,000 mid-aged and older men and women nationwide, and SWAN (Study of Women's Health Across the Nation), an ongoing annual study of 3,302 multi-ethnic midlife women. We hypothesize that neighborhoods with lower SES, fewer resources for physical engagement, fewer resources for intellectual engagement and less favorable social environments (fewer resources for social engagement and higher stress levels) will predispose to poorer physical and cognitive function. Aim 1 proposes cross-sectional investigation of how the neighborhood environment is associated with physical and cognitive function after adjusting for individual-level factors, and how neighborhood factors contribute to cross-sectional health disparities in function. Aim 2 will investigate whether neighborhood factors and changes in neighborhood factors are related to changes in physical and cognitive function over time as well as the contribution of neighborhoods to differential changes in function over time by SES and race/ethnicity. A variety of analytical methods will be used to address the causal inference challenges present in neighborhood health effects research. The analyses are embedded in a training and mentoring plan including training in substantive areas related to cognition, function, and aging as well as methodologic training in longitudinal data analyses, propensity scores, econometric techniques and causal inference generally. This application will provide preliminary data and the mentoring necessary to establish the applicant as an independent investigator and promote the development of a successful R01 application.

Public health relevance
Project Narrative Prevalence of physical and cognitive functioning problems increases dramatically with age, and gender and health disparities highlight the vulnerable status of minorities and women. There is substantial public health relevance in extending our understanding of how aspects of the neighborhood environment may impact physical and cognitive function because all three factors are modifiable. Deepening our understanding of the role that neighborhoods play in health disparities in functioning will provide valuable information in addressing these disparities. __SpecificAimsTextDelimiter__ 1 10. Specific Aims Physical functioning problems increase with age, reaching 30% in older Americans [1]. Cognitive decline is also age related, with prevalence rates of cognitive impairment ranging from 19.2% in those aged 65-74 up to 38% in those aged 85 and older [2]. Minorities [3-5] and women, particularly in the midlife [6,7], are vulnerable to declines in physical and cognitive functioning. There is an emerging recognition that environments including residential environments are important in shaping health behaviors and health outcomes [8-13]. Aging persons may be particularly vulnerable to the neighborhood environment since they tend to have a smaller range of routine travel and thus have increased exposure to proximal environments [13-14]. A handful of cross-sectional and prospective investigations have supported associations between greater neighborhood deprivation and poorer physical [15-19] and cognitive [20,21] functioning, but the research is very limited. This proposed study is a secondary analysis of two separate but complementary datasets. The ongoing MESA (Multi-Ethnic Study of Atherosclerosis) study investigates the prevalence, correlates, and progression of subclinical cardiovascular disease in over 6,000 mid-aged and older men and women nationwide. The SWAN (Study of Women's Health Across the Nation) is an ongoing annual study of multi-ethnic midlife women. We hypothesize that neighborhoods with lower socioeconomic status (SES), fewer resources for physical engagement, fewer resources for intellectual engagement and less favorable social environments (fewer resources for social engagement and higher stress levels) will predispose to poorer physical and cognitive function. Both cohorts used in this investigation offer multi-ethnic samples with diverse geographic locales. The study cohorts complement one another: MESA offers gender and race/ethnic diversity and rich measures of neighborhood social and physical environments, including GIS and survey measures, allowing detailed investigation of a range of neighborhood features. SWAN offers longitudinal data over a long time period making creation of a variety of neighborhood measures from county, state and national geographic datasets possible, allowing investigation of long and short-term predictors of change. Identifying neighborhood features that are associated with trajectories of physical and cognitive function represents an important avenue to a potentially valuable public health prevention strategy to forestall or prevent decline in these conditions. Aim1: Cross-sectional associations between neighborhood environment and function: To investigate how the neighborhood environment is associated with physical and cognitive function cross-sectionally after adjusting for individual-level factors. (Aim 1 hypotheses will be investigated in MESA and SWAN separately.) 1.1 Persons with lower neighborhood SES, higher community stress levels and fewer resources for physical, social and intellectual engagement will have worse physical function scores after adjusting for individual- level factors. 1.2 Persons with lower neighborhood SES, higher community stress levels and fewer resources for physical, social and intellectual engagement will have worse cognitive function scores after adjusting for individual- level factors. 1.3 The neighborhood associations with physical and cognitive function will be stronger in minorities, older persons and those with lower SES. 1.4 Associations between the neighborhood environment and physical function will be partly explained by individual-level factors including chronic conditions (e.g. hypertension), health behaviors (e.g. physical activity), and psychosocial processes (e.g. social support). 1.5 Differences in neighborhood environments will partly explain race/ethnic and socioeconomic differences in physical and cognitive function. Aim 2: Longitudinal associations between neighborhood environment and functioning: To investigate how the neighborhood environment is associated with physical and cognitive function across time after adjusting for individual-level factors. (Aim 2 hypotheses will be investigated in SWAN.) 2.1 Lower neighborhood SES, higher community stress levels and fewer resources for physical, social and intellectual engagement will be associated with greater declines in physical function scores over time after adjusting for individual-level factors. 2.2 Lower neighborhood SES, higher community stress levels and fewer resources for physical, social and intellectual engagement will be associated with greater declines in cognitive function scores over time after adjusting for individual-level factors. 2.3 Unfavorable within-person changes in neighborhood environments (e.g. increasing poverty) will be associated with larger within-person decline in cognitive and physical function. 2.4 Differences in neighborhood environments will partly explain race/ethnic and socioeconomic differences in trajectories of physical and cognitive function.